Structure and function of platelet glycoprotein Ib-IX-V complex

PROJECT SUMMARY
This proposal is to continue our studies of glycoprotein (GP)Ib-IX-V complex that is essential to platelet
physiology. Initially identified as a platelet sensor for flow shear stress through its interaction with von
Willebrand factor (VWF), GPIb-IX-V plays a critical role in hemostasis and thrombosis. It is also tapped for
additional roles in inflammation, platelet genesis and clearance. Malfunction of this multi-subunit receptor
complex can lead to severe bleeding diathesis and contribute to many cardiovascular diseases. During the
current funding period we have identified, for the first time, a mechanosensory domain (MSD) in the
juxtamembrane region of the GPIbα subunit. The MSD unfolds upon tension-mediated pulling on an
engaged A1 domain of VWF or anti-GPIbα antibody. Furthermore, unfolding of the MSD induces signaling
through GPIb-IX, resulting in accelerated platelet clearance and thrombocytopenia. Our study on MSD has
initiated a new paradigm for the mechanosensing and activation mechanism of GPIb-IX-V. First, neither
the affinity nor the binding epitope of an anti-GPIbα antibody is the key to GPIb-IX activation. Instead, a
tensile force generated by the bound antibody is what is needed to unfold the MSD and activate GPIb-IX.
Second, antibody-mediated platelet crosslinking may be a common feature for soluble ligands to generate
tension on GPIb-IX and to activate it. Third, activation of GPIb-IX by plasma VWF or anti-GPIbα antibodies
results in receptor desialylation and exposure of β-galactose residues on the platelet surface, which have
been shown in recent studies to mediate platelet clearance. These findings, along with our preliminary
observations under adherent conditions, suggest the existence of hitherto unidentified elements
modulating the mechanical dynamics and function of the MSD. To continue our investigation of the
structure-function of GPIb-IX-V, we propose here to identify and characterize the elements activating and
modulating the MSD with multidisciplinary approaches in three Specific Aims. Aim 1 is to define the
structural and mechanical elements of physiological ligand VWF that are required to activate GPIb-IX. Aim
2 is to identify and characterize residues and novel modulatory elements in the MSD that are critical to its
dynamics and function. Aim 3 is to explore the mechanical regulation of GPIb-IX activity by GPV through
their interaction. Completion of the proposed study will critically advance the fundamental mechanosensing
and mechanoregulatory mechanism of the GPIb-IX-V complex and the platelet. It will also establish a solid
structural foundation for understanding the diverse functional roles of GPIb-IX-V in platelet clearance,
hemostasis, and thrombosis.

Public health relevance
PROJECT NARRATIVE The objective of this proposed project is to understand how a protein receptor complex on the platelet surface called GPIb-IX-V complex can sense the blood flow and transmit this information into the platelet. GPIb-IX-V is involved in hemostasis, thrombosis, and platelet clearance. Elucidating this mechanosensory process and its regulation will help us to understand how platelets functions and to potentially develop novel therapeutic strategies to treat bleeding and thrombotic disorders.